THERAPY OF HERPES SIMPLEX VIRUS INFECTION IN HIV INFECTED PATIENTS--ACTG 172

Treatment of acyclovir resistant chronic mucocutaneous Herpes Simplex Virus infection in patients with HIV-infected patients.